Statistical Core (formerly Statistics and Data Coordinating Center)

STATISTICS AND DATA COORDINATING CENTER (S&DCC) The Statistics and Data Coordinating Center (S&DCC) will work closely with leadership and staff of the Center for Native Oral Health Research (CNOHR) to provide biostatistical, data management, programming, methodological, and electronic communications support for the CNOHR research programs. The S&DCC PI, Dr. William Henderson, will serve on the CNOHR Executive Committee (EC), along with CNOHR Research Program and Administrative Center (RPAC) PI, Dr. Judith Albino, and the designated representative from the NIDCR. This section of the application describes the organizational structure of the S&DCC, including our multimethods team, the implementation approach, the analysis approach for the intervention studies, the electronic communications network/platform, and other support components of the S&DCC.